Enhancing Seated Stability and Reaching After Spinal Cord Injury

PROJECT SUMMARY/ABSTRACT The overall goal of the proposed research is to develop new control systems to restore seated function and enhance the postural stability of the trunk for individuals paralyzed by spinal cord injury (SCI). Systems that provide persons with the ability to sit erect, alter their seated posture, and maintain balance by automatically adjusting stimulation to the paralyzed muscles will be designed, optimized in simulation, and evaluated experimentally in nine volunteers with SCI. The project will result in a unique, comprehensive trunk balance control system that extends the capabilities and improves the safety of all currently available trunk neuroprostheses. The first aim of the study is to design, deploy and test an advanced neuroprosthesis to stabilize the trunks of individuals with SCI and maintain upright sitting. A disturbance-rejection controller using information from body-mounted sensors will be optimized to maintain erect posture for disturbances in all directions around the seated user. In that way restrictive chest straps or custom seating adaptations are completely eliminated and the likelihood of falling from the wheelchair reduced to a minimum. The objective of the second aim is to tune, characterize and asses the performance of a system that will allow individuals with paraplegia to safely deploy their trunks and maintain the stability of non-erect postures, thus expanding their reachable workspace. Performance of this posture-changing controller will be determined in a series of experiments that deploy the trunk to different positions away from the backrest and testing the ability to remain steady at the desired postures. In the third aim, we will characterize the consistency, accuracy and fidelity of the implanted sensors in the new networked neuroprosthesis (NNPS). This will be done by collecting data in a series of experiments and developing an algorithm that will fuse the signals from the various sensors to produce a robust feedback signal suitable for control studies. Thereafter we will implement the disturbance-rejection and posture-changing control systems without external components with this new technology. This application addresses the main mission of the National Institutes of Health (NIH) to help lead the way toward important medical discoveries that improve people's health and save lives. In particular it coincides with the missions of NINDS to reduce the burden of neurological disease, NIBIB to improve health by leading the development and accelerating the application of biomedical technologies, and NCMRR to foster development of scientific knowledge needed to enhance the health, productivity, independence, and quality-of-life of people with disabilities.

Public health relevance
PROJECT NARRATIVE This project will determine the feasibility of a new comprehensive trunk postural control system for implanted neuroprostheses that restores functional seated balance to individuals with various levels of spinal cord injury (SCI). Advanced biomechanical modeling and computer simulation techniques will be used to develop new control elements that a) maintain the stability of the trunk at the nominal erect posture; b) allow users to deploy their trunk away from the nominal upright seated position whenever they wished to do so; c) maintain the new user-selected posture by automatically adjusting stimulation based on any changes in trunk tilt away from that posture and d) allow users to return to the nominal erect posture; all without loss of stability. The control systems will define new interventions that increase the safety of people with SCI to undertake activities of daily living in environments typically found in the office and home that would otherwise be impossible to accomplish while in a seated position without the potential of falling off the wheelchair or seat.